Pennsylvania Surveillance for Antimicrobial Resistant-enteric Bacteria in Retail Food

Pennsylvania Surveillance for Antimicrobial Resistance in Bacteria from Retail Foods
Abstract
Antimicrobial resistance in foodborne pathogens of animal origin, including Salmonella and
Campylobacter species, is a danger to public health. Pennsylvania is home to large rural and
urban populations, both in close proximity to major food production centers. As such,
Pennsylvania provides a high leverage point for the detection of emerging antimicrobial
resistance. Pennsylvania’s continued participation in the National Antimicrobial Resistance
Monitoring System (NARMS) retail food surveillance provides two key benefits. First, the
program contributes to the FDA’s regulatory oversight for antimicrobials, which directly benefits
residents of Pennsylvania and the whole nation. Second, it strengthens integrated One Health
surveillance for enteric bacteria, which can detect threats that may cross human and animal
populations.
By using whole genome sequencing to compare bacteria from food samples and patients, our
outbreak investigations quickly lead to trace-back of contaminated products and prioritization of
interventions such as facility inspections by regulators. Analyses of integrated genomics data
from food and human sources also enhances surveillance for antimicrobial resistance in enteric
bacteria. Key outcomes from our program strategy include better coordination and exchange of
data and isolates with the FDA, better insights into severe infections acquired from food of
animal origin, and improved timelines of the surveillance system. Additionally, our efforts will
improve data quality and completeness of records and increase dissemination of NARMS
findings to support One Health antimicrobial stewardship efforts in diverse settings.

Public health relevance
Pennsylvania Surveillance for Antimicrobial Resistance in Bacteria from Retail Foods Project Narrative Conducting surveillance for enteric bacteria in retail food as part of the National Antimicrobial Resistance Monitoring System (NARMS) provides critical data to the FDA for the regulatory oversight of antibiotics. The comparison of whole-genome sequenced isolates from retail food and patient samples—such as Salmonella—significantly contributes to improvements in food safety. This analysis facilitates outbreak investigations, the trace-back of contaminated products, and offers key insights into severe drug-resistant foodborne infections. These findings further support One Health antimicrobial stewardship efforts in diverse settings.